Social Support as a Facilitator of Adherence to HIV Pre-Exposure Prophylaxis Among Young MSM of Color

Project Summary Over the past decade, HIV infections have increased by 87% among young men who have sex with men (YMSM) of color. Reversing this trend will require the use of HIV pre-­exposure prophylaxis (PrEP). However, increasing PrEP access alone will not change the face of the epidemic. As PrEP efficacy is highly correlated with levels of adherence, and no evidence based interventions yet exist to support PrEP adherence, it will be crucial to identify factors associated with improved adherence to PrEP in YMSM. Social support has been described as a facilitator of adherence in qualitative data from PrEP trials. Understanding how social support operates in the PrEP-­adherence relationship is essential prior to developing potential social support-­based interventions to optimize PrEP adherence. However, no studies have yet formally analyzed the potential association between social support and PrEP adherence among YMSM. In response to the critical need for research delineating the role of social support in PrEP adherence for YMSM, we propose the following specific aims:1) to discover themes related to identification and utilization of HIV pre-­exposure prophylaxis (PrEP)-­related support and social support network structure within social support networks of YMSM of color receiving PrEP;? and 2) to determine the association between social support and current and sustained adherence to PrEP among a cohort of YMSM of color. To achieve aim 1, we will conduct a mixed methods qualitative and network analytic study using in-­depth interviews and sociograms to explore themes of how participants identify PrEP-­related support figures, how social support is structured, and the ways in which support figures may facilitate PrEP adherence. For aim 2, we will use a cross-­sectional study design to test for an association between social support, as measured with a well-­validated multi-­dimensional survey instrument, and current PrEP adherence using a novel urine assay to detect tenofovir;? and a longitudinal cohort design to test for an association between social support as measured above and sustained PrEP adherence using pharmacy refill data. The proposed research is both innovative and relevant to the NIH HIV/AIDS priority of supporting research to develop methods of PrEP delivery that mitigate adherence issues. The proposed research will require skills in epidemiology, biostatistics, qualitative research methods, and network analytics. The Kirschstein-­NRSA Individual Postdoctoral Fellowship will thus be essential to the success of this research by providing funding for the applicant to complete qualitative methods and introductory network analytics courses through the Masters of Science in Health Policy Research and provide a second year of courses in advanced topics in epidemiology and networks under the supervision of a highly qualified, multidisciplinary mentorship team who will guide the candidate in her career development. The longer-­term objectives of the applicant are to complete data analysis, disseminate results through presentations and publication, and use the results as a foundation for a future K award application.

Public health relevance
Project Narrative While HIV pre- exposure prophylaxis (PrEP) has emerged as an essential tool to reverse the dramatic increase in new HIV infections among YMSM of color in the United States, harnessing its preventative benefit will require identification and utilization of facilitators of adherence, such as social support. Through our proposed study, we aim to build the foundation for potential social support- based interventions to improve PrEP adherence by conducting a qualitative and network analyses exploring how PrEP- related social support figures are identified and how PrEP- related support manifests in social support networks of YMSM of color. In addition, we aim to analyze whether current and sustained PrEP adherence differs based on the magnitude of social support using a well- validated survey instrument, a novel urine assay to detect tenofovir concentration, and pharmacy refill records.